New York Department of Agriculture and Markets - Division of Food Laboratory collaborative work through the Laboratory Flexible Funding Model to support an integrated food safety system (IFSS)

NY AGM Food Laboratory – Overall Project Summary/Abstract:
The New York State Department of Agriculture and Markets (NY AGM) has an
expansive and robust food safety inspection program and a regulatory food safety testing
laboratory. The Food Laboratory, a division within the NY AGM, has a mission to provide expert
state of the art analytical testing in support of food safety programs in New York State. The
Food Laboratory, through food testing, provides support to the divisions of Food Safety and
Inspection and Milk Control and Dairy Services. It is the primary servicing laboratory for the New
York manufactured food regulatory program and is accredited to the ISO/IEC 17025 standard
and AOAC ALACC criteria. The Food Laboratory has comprehensive testing programs for
microbiological and chemical contamination in food and beverages.
If funded for the Laboratory Flexible Funding Model, the Food Laboratory will maintain
the resources and personnel necessary to cover the testing of more than 1,000 samples
according to the Food Laboratory Sampling Plans. The laboratory will maintain a quality
management system compliant with the managerial and technical requirements of ISO/IEC
17025 and continue to be accredited by a recognized accreditation body. It will participate in
proficiency testing or competency exercises on an annual basis to maintain analyst
competency. If funded, the following activities will be part of Food Laboratory deliverables:
participation in small-scale method development, method validation research, and matrix
extension research; participation in related training and mentorship to other State laboratories, if
requested; FERN membership and participation in conference calls, meetings, and support of
FERN activities; key personnel will be sent to all annual LFFM Face-to-Face Meetings; quarterly
summaries of all food samples collected and analyzed under the Sampling Plans, notification of
FDA project manager and technical lead of any presumptive positive samples promptly, full
laboratory packages of any violative sample after laboratory report is released on time,
maintenance of a 20.88 confidentiality agreement with FDA, outline plans for capacity/capability
development, and participation in at least one FDA requested assignment annually related to
human and animal food. The Food Laboratory will support the integrated food safety system by
sharing laboratory results with the FDA when considering enforcement actions for surveillance
and regulatory purposes. The laboratory is also supporting FDA’s initiative to expand laboratory
testing capacity when new technologies or procedures are available.

Public health relevance
NY AGM Division of Food Laboratory Project Narrative: Overall The New York State Department of Agriculture and Markets (NY AGM) has a comprehensive food safety inspection program and a regulatory food safety testing laboratory. The Division of Food Laboratory supports integrated food safety system (IFSS) activities by (1) participating in the annual LFFM Face-to-Face (F2F) meeting and Genome Trackr meeting, (2) presenting findings in either a poster or an oral presentation during the LFFM F2F meeting, (3) continuing to be a FERN member, (4) maintaining a valid 20.88 agreement with FDA, (5) maintaining laboratory facilities and personnel necessary to complete regulatory activities, (6) participating in routine Track webinars/meetings, (7) responding to communications and inquiries from FDA/LFFM staff promptly, (8) participating in, and passing, annual chemistry and microbiology food related proficiency tests offered through a suitable proficiency testing program, (9) participating in small-scale chemistry and microbiology food testing related method development, method validation research, and matrix extension research, as requested by the FDA, (10) supporting pivot, overflow, emergency, surge capacity, and FDA- issued assignment requests, (11) maintaining our ISO 17025 accreditation, (12) providing chemistry and microbiology food testing related training and mentorship to other state laboratories, as requested, (13) ensuring methods used for analyzing samples under this project have been validated, with the exception of emergency situations, as identified by FDA, where the rapid development and deployment of a method is needed to immediately address an outbreak event, (14) following current version of LFFM Sample Guide for proper sampling and laboratory data documentation, (15) following current version of LFFM Sample Guide for timely notification of presumptive and confirmed positive samples to identified points of contact, (16) following current version of LFFM Sample Guide for LFFM Sample Follow-up Procedures, to includes SRP-led follow-up and coordination with FDA, (17) supporting the regulatory programs such as Manufactured Food Regulatory Program Standards and Produce Safety with jurisdiction for products being collected and tested, (18) following current version of LFFM Sample Guide for sample plan proposal development, sample collection, and laboratory/SRP coordination, (19) supporting that each regulatory program participating in LFFM must collect at least 15% of planned samples for which they have jurisdiction, annually, and (20) providing a detailed quarterly summary of all samples collected and analyzed using the appropriate discipline's Quarterly Sample Summary form (OMB #0910-0909) through the FERN website, or other FDA-approved system.